Expanding the reach of the Nutritious Eating with Soul (NEW Soul) program: A Type 2 hybrid effectiveness-implementation trial

Project Summary/Abstract
African Americans (AAs) are disproportionately affected by cardiovascular disease (CVD) and obesity. AA
vegetarians/vegans have significantly lower risks of hypertension and diabetes as compared to AA omnivores.
Vegan soul food restaurants have emerged as a potential community partner for introducing patrons to healthy
versions of familiar soul food cuisine. To explore the potential impact of this intervention on AAs with
overweight or obesity who were not already following vegan diets, we conducted the Nutritious Eating with
Soul intervention (NEW Soul; R01HL135220), delivered in a university setting in Columbia, SC (n=159 AAs;
vegan vs. low-fat omnivorous diet, both focused on soul food). We completed 3-month assessments with high
retention rates (88%) and significant weight loss (vegan -2.2±2.8 kgs; omnivorous -1.2±2.7 kgs; p=0.03).
We propose to examine the effectiveness and implementation of a remotely-delivered, 3-month NEW Soul
program. We will work with two vegan soul food restaurants (see letters of support). We have the following
aims:
Aim 1: Evaluate the effectiveness of the 3-month NEW Soul restaurant-delivered program on two important
factors in the development of CVD (body weight and diet quality) among AAs with overweight or obesity.
Participants (n=228) will be randomized to one of two conditions: 1. Remotely delivered live weekly classes
with restaurant vouchers (intervention) or 2. restaurant voucher-only (active control).
Aim 2: Conduct a cost-effectiveness analysis of delivering the online intervention plus voucher vs. voucher-
only with the outcome of cost/change in weight, HEI and quality adjusted life year (QALY). This includes
estimating costs of the intervention itself (e.g., training, delivery, infrastructure).
Aim 3a: Examine the implementation of the NEW Soul study. Guided by the implementation outcome
framework by Proctor, et. al., and the implementation strategies described by Waltz, et. al., we will examine the
feasibility and utility of the NEW Soul implementation strategies (e.g., provide iterative assistance, provide
ongoing training and consultation, centralize technical assistance) in restaurant settings. We will employ
qualitative (semi-structured interviews with intervention staff and focus groups with participants), and
quantitative (surveys with participants) research methods, which will be guided by CFIR domains (intervention
characteristics, inner setting, outer setting, characteristics of individuals, and process).
Aim 3b: Building on the findings from Aims 1-3a, we will conduct key informant interviews with intervention and
restaurant staff to identify areas to prepare the intervention for widespread adoption by vegan soul food
restaurants across the southeast. We will focus on the design quality and packaging, part of the CFIR
“intervention characteristics” domain.

Public health relevance
Project Narrative Our proposed project will test the implementation of the NHLBI-funded NEW Soul program and how the program can lead to significant improvements in dietary and weight outcomes. The goal of this study is to develop a ready to adopt intervention in African American owned vegan restaurants. This study will test an entirely remotely delivered behavioral intervention that has the ability to be scaled up so that reach of this treatment approach is broad.